All of Us Research Program New York Consortium

Since 2016, the All of Us Research Program (AoURP) has striven to build the foundation for major advancements in precision medicine. Mount Sinai will continue to maintain regulatory requirements, continue its engagement and retention efforts, and achieve EHR milestones to contribute to All of Us’ national dataset.

Public health relevance
The AoURP at Mount Sinai contributes data from participants to a dataset that researchers could use to advance precision medicine, study diseases, and determine effective treatments. In the long term, data and insights from the AoURP may be used to determine new approaches for preventing disease.